Investigating the roles of METTL3 and M6A modification in colorectal cancer progression

PROJECT SUMMARY/ABSTRACT
Colorectal cancer (CRC) is a leading cause of cancer-related deaths worldwide, particularly in Western countries,
where it accounts for approximately 10% of all cancer fatalities. In the United States, CRC is the third most
common cancer (excluding skin cancers), with around 160,000 new cases reported in 2023. Among these cases,
metastatic CRC is present in 20% of patients at initial diagnosis and constitutes half of all CRC cases, with a 5-
year survival rate of only 14%. Understanding the mechanisms driving CRC progression is crucial for improving
diagnostic and therapeutic strategies. Recent research highlights the role of METTL3, an m6A (N6-
methyladenosine) methyltransferase, in promoting CRC. These studies underscore the importance of
epitranscriptomic regulatory pathways, particularly those related to m6A, in CRC tumorigenesis. However, the
specific mechanisms underlying these pathways remain largely unexplored. The primary objective of this
proposal is to elucidate how METTL3 and m6A modifications facilitate CRC progression, identify novel METTL3
coordinating factors and their targets in CRC, with the long-term goal to develop new diagnostic and therapeutic
interventions. To achieve this, we used an innovative sequencing approach that combines long-read Nanopore
Direct RNA sequencing (RNA-seq) with short-read Illumina RNA-seq in METTL3 knockdown CRC cells. Our
long-read sequencing accurately mapped METTL3-dependent m6A sites across the CRC transcriptome. By
integrating these results with short-read RNA-seq and patient data from TCGA, we identified several clinically
relevant genes whose RNA stability and alternative splicing (AS) events are regulated by METTL3. Additionally,
we pinpointed factors that mediate METTL3's functions in CRC, particularly the m6A readers involved in RNA
stability and AS regulation. We also experimentally validated some METTL3 targets and confirmed YTHDF1 as
an m6A reader that mediates RNA stability regulation. These preliminary findings provide a strong rationale for
further exploring METTL3's roles in CRC, with the following specific aims: (1) To understand how METTL3
regulate RNA stability to promote CRC, and (2) To investigate the effect of METTL3 in regulating AS in CRC.
The study will be conducted under the mentorship of Dr. Christopher Maher, co-mentorship of Dr. Jason Weber,
and through the Cancer Biology program at Washington University, known for its leading genetics research. The
Maher lab is a great fit for this project, with their expertise in molecular biology, bioinformatics, genomics, and
CRC research. Dr. Weber’s expertise in RNA biology and cancer biology aligns perfectly with the objectives of
this study. Training will focus on (1) advancing experimental biology and bioinformatics skills, (2) enhancing
clinical engagement and translational medicine knowledge, and (3) developing scientific communication,
leadership, and mentorship capabilities, all essential for a successful career in cancer research. This research
is poised to make a significant impact by providing a comprehensive understanding of how METTL3 promotes
CRC progression and holds substantial potential for clinical translation to improve patient care in CRC.

Public health relevance
PROJECT NARRATIVE Colorectal cancer (CRC) and metastatic CRC are major causes of cancer-related mortality, with METTL3, an m6A (N6-methyladenosine) methyltransferase, serving as a key oncogenic factor in their progression. Therefore, understanding how METTL3 coordinates with various factors to drive CRC progression through m6A modification is crucial. This study advances the field by introducing a comprehensive sequencing approach, a novel analytical pipeline, and genetic models to identify METTL3 coordinating networks and their target genes in CRC, offering potential for innovative diagnostic and therapeutic strategies.